Phase II Trial of targeted Radiation with no castration for mcrpc (POTENT-C)

All modern randomized controlled trials for patients with mCRPC have included a backbone of continuous
medical or surgical castration in control and experimental arms. Unfortunately, continuous medical castration
virtually guarantees ongoing side effects that are predictably detrimental to quality of life. Theoretical rationales
notwithstanding, there is no definitive empirical evidence that maintaining castrate levels of testosterone is
required during ongoing treatment of patients with mCRPC. In fact, modern prospective data strongly suggests
that (1) ongoing medical castration therapy is likely not required if patients are receiving active non-AR directed
therapy, and (2) restoration of physiologic testosterone investigated in combination with such therapy will
improve quality of life.
Most mCRPCs over-express PSMA which is amenable to PSMA targeted radiopharmaceuticals that
deliver beta-particle radiation selectively to PSMA positive cells and their immediate surroundings. Metastasis
directed SBRT enables safe and accurate precision delivery of ablative doses of ionizing radiation to metastatic
lesions independent of PSMA expression. Comprehensive systemic targeted radiopharmaceutical therapy
combined with metastasis directed ablative tumor directed therapy might not only delay progression, but also
create a critical window of opportunity to restore physiologic levels of testosterone and thereby potentially enable
Veterans time with normal vitality, hormonal function, and even sexual function.
We propose: a Phase II Trial Of TargetEd Radiation with No CastraTion for mCRPC (POTENT-C). By
leveraging advances in non-AR directed active therapy for mCRPC, our proposal promises to improve treatment
efficacy and quality of life for Veterans with mCRPC. Specifically, we hypothesize that comprehensive non-
hormonal therapy in the form of PSMA targeted radioligand therapy combined with metastasis directed SBRT,
followed by physiologic restoration of testosterone will (1) improve efficacy of therapy for Veterans with
mCRPC while simultaneously (2) improving quality of life.
POTENT-C is a single arm Phase II clinical trial of PSMA targeted radiopharmaceutical therapy and
comprehensive metastasis directed therapy followed by palliative testosterone replacement therapy (TRT) in
Veterans with mCRPC who have progressed on at least one prior second generation anti-AR therapy. We
hypothesize that this therapeutic approach will both improve clinical outcomes and quality of life for Veterans.
Planned therapeutic interventions include two cycles of Lu-177 PSMA PNT2002 separated by 8 weeks with
intervening metastasis directed SBRT to all visible sites of disease. Four weeks after this planned therapy,
Veterans are re-imaged and those without suspicion of radiographic progression are planned for symptomatic
palliation with testosterone replacement therapy (TRT). • The primary endpoint is six-month radiographic
progression free survival per PCWG3 criteria. Secondary endpoints include safety, additional measures of
therapeutic efficacy, and patient reported quality of life using validated tools. Exploratory endpoints investigate
possible prognostic value of imaging and genomic derived biomarkers.
The POTENT-C trial challenges long-standing paradigms of maintaining castrate levels of testosterone
in patients treated for mCRPC. If Veterans with mCRPC can be effectively treated without the need for ongoing
castration and without detriment to survival, this would undoubtedly be broadly celebrated by Veterans with
prostate cancer and their partners. It would also shift fundamental understandings of castration resistant disease
biology. If successful, the fundamental treatment paradigm for mCRPC requiring indefinite castration therapy
would pivot. This would be transformative.

Public health relevance
Prostate cancer is diagnosed in approximately 12,000 American Veterans annually accounting for one third of all cancer diagnoses in American male Veterans. It is the second leading cause of cancer death in American male Veterans, and the number one cause of cancer-specific death amongst non-smoker Veterans. In addition to death, the treatments for prostate cancer have frequent and predictable detrimental impacts on Veterans’ quality of life. This burden is most intensely experienced by Veterans living with metastatic prostate cancer where the backbone of treatment is indefinite medical castration therapy. By leveraging advances in non-hormonal active therapy, our proposal promises to improve treatment efficacy and quality of life for Veterans with lethal prostate cancer. Specifically, comprehensive non-hormonal therapy in the form of targeted radiopharmaceutical therapy combined with metastasis directed precision radiotherapy, followed by physiologic restoration of testosterone will improve efficacy of therapy while simultaneously improving quality of life.